Defining the cellular and molecular mechanism of IDO2 function driving autoimmune vs.protective immune responses

Project Summary
Autoimmune diseases are chronic inflammatory diseases that affect more than 50 million Americans, leading to
pain, disability, and increased mortality. While drugs to treat autoimmune diseases exist, alleviation of
inflammatory symptoms is often associated with severe side-effects, including increased susceptibility to
infections and cancer. Our proposal addresses the urgent need to identify new therapeutic targets to
address the underlying causes and associated symptoms of these debilitating diseases. In this proposal,
we will investigate indoleamine-2,3-dioxygenase (IDO2) as a novel immunomodulatory target for autoimmune
diseases. IDO2 is one of two closely related tryptophan catabolizing enzymes expressed primarily in immune
cells. Using a combination of genetic and pharmacological studies in the KRN model of inflammatory arthritis,
we identified IDO2 as an essential mediator of autoantibody-mediated inflammatory responses and discovered
a novel non-enzymatic function of IDO2 that drives autoimmune responses leading to disease. Mechanistic
studies implicate the transcription factor Runx1 as a potential component of this previously unknown IDO2
signaling pathway. IDO2 appears to be essential for only some B cell functions, as IDO2 deficient mice develop
normal immune cell compartments and mount productive immune responses to challenge with some, but not all,
model antigens in vitro and in vivo. A better understanding of IDO2 biology, in particular the roles that enzymatic
and non-enzymatic activity have in regulating immune function is necessary to develop IDO2 as a potential
therapeutic target for autoimmune disease. Our working hypothesis is that IDO2 modulation of immune
responses involves both enzymatic and non-enzymatic pathways with autoreactive B cell activation/autoantibody
production dependent on IDO2’s non-enzymatic function. We propose that this differential use of non-
enzymatic vs. enzymatic IDO2 pathways can be specifically targeted as a therapeutic strategy to inhibit
IDO2 function in autoimmune responses without affecting its role in protective immunity. In this proposal,
we will use preclinical models of autoimmune arthritis, IDO2 and Runx1 conditional knockout mice and
overexpressing cell lines, and whole transcriptome RNA-seq analysis to define the cellular and molecular
mechanism mediating IDO2 non-enzymatic function (Aim 1). We will then use catalytically inactive IDO2 knock-
in mice and a novel IDO2-targeting antibody, together with IDO2-dependent models of autoimmunity and
protective immunity, to determine if differential use of non-enzymatic vs. enzymatic pathways distinguishes IDO2
function in autoimmune and protective immune responses (Aim 2). The potential long-term impact of this
project would move targeting non-enzymatic IDO2 function into development as a novel strategy to treat
autoantibody-mediated autoimmune diseases.

Public health relevance
Project Narrative Understanding the factors that contribute to the initiation and propagation of autoimmunity is important in the design of therapeutic strategies to treat these devastating diseases. The studies in the proposal will provide insights into the mechanism by which the immune system becomes activated to induce inflammatory autoimmune responses and explore a novel strategy to differentially target its role in autoreactive vs. protective immune responses. In the future, this strategy could lead to a new approach to treat autoimmune diseases without the immunosuppressive complications of current therapeutics.